Identification of blood biomarkers predictive of organ aging

Project Summary
As we age, our tissues and organs experience molecular and physiological damage that prevents them from
functioning properly and this ultimately leads to disease states. These changes are not only due to the aging
process itself but are largely influenced by the exposome which includes all non-genetic exposures
(environmental and behavioral). Depending on the complex interaction between the exposome of an individual
and their genetics, different organs deteriorate over time at a different pace, resulting in tissues with different
biological ages within the same individual. As the biological age of a given organ reflects its overall health and
functional capacity, biologically older organs are more likely to cause health problems increasing the risk of
diseases. Aging “clocks” powered by omics technologies (transcriptomics, proteomics, epigenomics, etc.) and
machine learning methods have been used to approximate the biological age of specific tissues. However,
tissue-specific clocks require omics data from a biopsy, making clinical adoption impractical. Therefore, there is
a critical need to develop simple diagnostic tools using readily accessible biological material to measure organ-
specific aging rates in an individual which can be translated into personalized actionabilities and enable accurate
evaluation of the efficacy of health-promoting interventions. Using blood, the pipeline of the immune system,
from aging cohorts we and others have demonstrated that accelerated aging, as evidenced by age-related
chronic inflammation (inflammaging) and dysfunctional immune systems, results in organ dysfunction and an
elevated risk of disease in older subjects. This is not surprising since inflammaging has been proposed to be a
common denominator of most, if not all, diseases of aging. In this proposal, we hypothesize that the biological
information to investigate the aging rates of a given organ is contained in the blood of the same individual and
thus, can be estimated using a collection of tissue-specific gene expression signatures matched with those from
blood samples. Here, we will assemble multiple public domain datasets within and outside of the NIH Common
Fund to create blood-based organ-specific clocks and enable rapid diagnostics of aging rates for a given organ
in an individual. To do so, we will use transcriptomic data across multiple tissues and matched blood from the
Genotype-Tissue Expression (GTEx) database to construct a computational framework that calculates the rate
of aging of 45 tissues in an individual using blood gene expression. We will validate the resulting models to
predict organ-specific aging in disease states specific to the organ of interest, and we will assess the influence
of lifestyle factors including diet, exercise and smoking on the aging of different organs using data from the
Framingham Heart Study. Finally, we will use the Library of Integrated Network-based Cellular Signatures
(LINCS) to identify candidate compounds that can restore the gene expression changes in the blood associated
with tissue aging to optimal levels.

Public health relevance
PROJECT NARRATIVE The proposed research is of significant clinical relevance as it enables the early detection of accumulated tissue damage at the subject level, thereby providing opportunities for developing personalized preventative interventions. Additionally, by predicting tissue aging at the level of individual organs through the analysis of blood samples, the proposed study has the potential to avoid unnecessary diagnostic tests and ‘one-size-fits-all’ treatment approach or other interventional procedures, resulting in huge cost savings for healthcare systems and ultimately benefiting public health. Furthermore, this study also provides new insights into how lifestyle and environmental cues can differentially impact aging across tissues and proposes a series of candidate compounds that may prevent age-driven tissue damage and diseases.